PET STUDIES OF PHEOCHROMOCYTOMA--ENDOCRINE AND METABOLIC APPROACHES

The purpose of this study is to explore the relative merits of approaches which utilize endocrine (catecholamine uptake) or metabolic (glucose utilization) features for the physiologic imaging of pheochromocytomas.